MRI Signatures of Response to High-Dose Radiotherapy in Rat Models of Cerebral Tumor

In some cases, e.g. small brain tumor metastases, responses to single or multiple fraction high-dose radiation
therapy (HD-RT) have been remarkable, suggesting that HD-RT tumor control is at least as effective as
biologically equivalent doses of conventional fractionated radiation therapy (CF-RT), even in radioresistant
tumors. Although the mechanism for its effectiveness is not well understood, HD-RT is becoming accepted
practice for a variety of tumors, including brain tumors.
Our recent preclinical study using MRI measures of short-term changes in tumor physiology after HD-RT in a
small-animal model of cerebral tumor suggests a physiological response that includes vascular effects, but is
multifactorial and temporally variable. Hypothesizing that these short-term changes may both explain the
increased effectiveness of HD-RT, and serve as a predictor of long-term response, we propose to investigate
the relationship between short-term physiological changes after HD-RT and long-term outcome as a result of
that therapy. In counterpoint, we will also study physiological changes during and after CF-RT. Detailed
poroelastic modeling is proposed to generate a map of local solid and fluid parameters (stress, flow) that will
help explain short-term changes in physiology. Aim 1 studies short-term changes in measures of tumor
physiology as predictors of response. Aim 2 describes the behavior of these same measures over the course
of CF-RT. Our long-range goals are to develop noninvasive biomarkers of response that predict tumor control
after HD-RT and CF-RT, and to describe physiological changes and related biomarkers that might be used to
optimize the order and timing of RT and adjuvant chemotherapies.

Public health relevance
Radiotherapy (RT) is an essential component in the treatment of brain tumors. This proposal uses dynamic magnetic resonance imaging (MRI) to explore why high-dose radiotherapy (HD-RT) is sometimes more effective in brain tumor treatment than conventional fractionated radiotherapy (CF-RT). By creating a comprehensive picture of tumor physiology during response to the differing radiotherapy strategies, early physiologic changes detected by MRI will be used to predict long-term treatment response, generating new tactics for the more effective use of RT in cancer treatment.